Administrative Core A

Summary Administrative Core
The Lung Cancer SPORE Administrative Core provides scientific and administrative oversight for all of the
SPORE Projects and Cores and the Developmental Research (DRP) and Career Enhancement (CEP)
Programs. It also provides the main interface with patient advocates, NCI program staff, external and internal
advisory boards, other Lung Cancer SPOREs, and other collaborating institutions. The SPORE Administrative
Core is co-Directed by the SPORE MPIs Drs. John D. Minna and David E. Gerber at UTSW, and Drs. Jack A.
Roth, and John V. Heymach at MDACC. The MPI plan details how they will work together and which aspects of
the SPORE administration they will focus on. As part of a planned transition, Drs. Gerber and Heymach will
assume full responsibility for the Administrative Core in years 3-5. Specific Aims for the SPORE
Administrative Core A are: 1. Direct the overall scientific quality and administrative management of the SPORE
and ensure effective communication between SPORE investigators and Patient Advocates; facilitate integration
of Research Projects and Cores within and between UTSW and MDACC; encourage and facilitate
multidisciplinary collaborations and cooperation (including Patient Advocates), as well as data and resource
sharing. 2. Prepare budgets, monitor budget expenditures, and implement corrective actions to stay within
budget. 3. Coordinate all SPORE investigator meetings, including monthly SPORE works in progress (WIPs)
videoconference/WebEx meetings, and Internal and External Advisory board meetings. 4. Coordinate access to
SPORE Core resources and oversee data quality control and validation determined by review of the Data
Sciences Core. 5. Ensure implementation of all federal, state, and institutional regulatory compliances. 6.
Oversee SPORE DRP and CEP activities by advertising DRP and CEP grant opportunities, and conducting DRP
and CEP grant review processes to ensure identification of the projects with the combination of the best science,
innovation, and potential for clinical translation; work with DRP and CEP applicants to help them use SPORE
resources and refine their projects for optimum translational potential, which will include identification of qualified
mentors for DRP and CEP awardees; establish and carry out policies for recruitment of women and minorities
to be involved scientifically in the SPORE and DRP and CEPs. 7. Enhance recruitment of women and minority
patients to participate in SPORE-related clinical trials. 8. Encourage and facilitate horizontal and vertical
collaboration of SPORE discoveries and investigators both within UTSW and MDACC and with other institutions.
9. Coordinate and maintain institutional commitments to the SPORE at UTSW and MDACC. 10. Communicate
and consult with the NCI program director frequently to ensure adherence to all reporting requirements, including
high-quality progress reports. 11. Coordinate and facilitate SPORE interactions with pharmaceutical and biotech
industry partners. 12. Coordinate and facilitate Patient Advocate involvement in the SPORE. 13. Coordinate and
facilitate resolution of scientific disputes.

Public health relevance
Administrative Core (Core A) Project Narrative The Lung Cancer SPORE Administrative Core provides scientific and administrative oversight for all of the SPORE Projects and Cores and the Developmental Research and Career Enhancement Programs. It also provides the main interface with patient advocates, NCI program staff, external and internal advisory boards, other Lung Cancer SPOREs, and other collaborating institutions.